The Role of TRPM3 Ion Channels in Opioid-Induced Analgesia and Pruritus

PROJECT SUMMARY
Spinal administration of morphine, a potent opioid, is commonly used to treat post-operative pain.
However, the desired opioid-induced analgesia consistently has a negative side effect of opioid-induced
pruritus, causing debilitating itch in the already distressed patient. The first line treatment is opioid antagonists,
but this may compete with the initial opioid treatment and cause the patient to choose between unwanted pain
or itch. Both sensations are closely related, but the mechanism of how opioids can cause both pruritus and
analgesia remains unclear.
Morphine acts on mu-opioid receptors (MOR) to inhibit the activity of pain-sensing neurons. MOR is a
G-protein coupled receptor (GPCR) coupled to the inhibitory Gi-heterotrimeric proteins (Gαi and Gβγ) which
cause downstream actions to inhibit depolarization of the neuron. One mechanism by which this inhibition
occurs is by direct inhibition by Gβγ on the Transient Receptor Potential melastatin 3 (TRPM3) ion channel, a
thermosensitive and nociceptive cation channel expressed on neurons. Recently, a naturally occurring splice
variant of TRPM3 that does not bind to Gβγ was identified. With this knowledge, a novel mouse line was
generated (TRPM3DEx17) in which all the TRPM3 channels express this isoform. Utilizing the TRPM3DEx17
mouse line we performed preliminary behavioral studies on morphine induced pruritus and analgesia.
Data showed that the TRPM3DEx17 mice experienced significantly less pruritus upon intrathecal injection
of morphine compared to WT. In the plantar incision model, TRPM3DEx17 mice had no change in morphine
analgesia when injected intrathecally in heat and mechanical nociception. Analgesia by morphine occurs
through inhibition of excitatory (Vglu2+) neurons, while pruritus occurs by inhibition of inhibitory (Vgat+)
neurons, or disinhibition, in the spinal cord. Interestingly, TRPM3 and MOR are more frequently coexpressed
on the itch-inhibitory Vgat+ neurons compared to the pain-excitatory Vglut2+ neurons, supporting our
behavioral findings. Thus, Aim 1 of the proposal will explore via in-situ hybridization, the co-expression of
TRPM3 and MOR in Vglu2+ and Vgat+ neurons in the TRPM3DEx17 mouse spinal cord, and use two reporter
mouse lines with GFP tagged excitatory and inhibitory neurons to perform whole-cell patch clamping of spinal
cord slices to compare morphine inhibition in each neuronal population. Aim 2 will attempt to overcome the
MOR inhibition of TRPM3 by co-injecting a TRPM3 agonist, pregnenolone sulfate, in the WT mice intrathecally
with morphine, and observe if opioid-induced pruritus can be alleviated while analgesia is maintained. These
results may suggest that TRPM3 is the main depolarizing ion channel responsible for the disinhibition of
pruritus and can be a potential target for alleviating morphine induced pruritus in patients undergoing opioid
therapy without affecting the desired analgesia.

Public health relevance
Project Narrative Spinal administration of morphine for pain relief in perioperative patients consistently cause a negative side effect of pruritus, but there is no effective treatment as the molecular basis of this debilitating side effect remains unclear. The proposed research will examine how the nociceptor TRPM3 ion channel, which is uniquely inhibited in neurons upon opioid receptor binding, affects the analgesia and pruritus evoked by morphine. The result of this work will improve our understanding of the cellular differences accounting for opioid induced analgesia and pruritus, and may provide potential therapies to reduce itching in patients without affecting the wanted pain relief.